Stanford Cancer Institute

Project Summary/Abstract
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as
NOT-CA-23-044.
The Stanford Cancer Institute’s (SCI) [2P30CA124435-14] mission is to leverage the broad and unique
strengths of Stanford University in basic science, bioengineering, population science, biostatistics, technology
development, clinical research, clinical care, and translation to (1) improve the diagnosis, treatment, and
outcomes of cancer patients; (2) understand cancer etiologies among diverse populations; and (3) decrease
cancer incidence in the SCI catchment area and beyond. SCI is committed to understanding and addressing
the cancer burden and reducing cancer disparities in our community. This proposal is in direct response to a
request from the SCI Community Advisory Board to foster research on strategies to reduce disparities in
access to evidence-based cancer care services in the catchment area at the patient and community level.
Cancer research discoveries over the last 30 years have stimulation critical innovations in cancer prevention
and care delivery, greatly improving cancer survival. However, communities with the greatest cancer burden
are often last to benefit from these innovations. Community benefit policies, including medical financial
assistance and community-building initiatives, aim to incentivize hospital systems to address the needs of
underserved patients and communities. Yet, the effectiveness of these policies in addressing persistent
disparities in cancer care access and burden are largely unknown.
Building on our prior research on community benefits, this proposal aims to engage community and health
system partners in the development of more equity-focused community benefit policies to improve cancer
outcomes and reduce disparities. Specifically, we seek to understand the complex and interacting factors that
drive community benefit spending in order to inform equity-focused allocation decisions in the 10-county SCI
catchment area. Activities proposed in this research supplement will establish a foundation for future research
studies to develop and validate a simulation-based tool to inform the allocation of community benefits in ways
that better address critical financial assistance needs for cancer patients and foster a more equitable allocation
of community benefit resources.

Public health relevance
Narrative Hospital based community benefit policies (e.g., charity care) are a critical lifeline to many cancer patients. However, recent studies suggest that patients and communities with the greatest needs may be least likely to benefit from these policies. In direct response to a request from the Stanford Cancer Institute Community Advisory Board, this study is designed to enhance our understanding of the factors that influence the allocation of community benefit dollars and foster bidirectional partnerships to redesign equity-focused policy solutions.